Predoctoral Training Program in Signaling and Cellular Regulation

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
Program Summary
The goal of this training grant proposal is to prepare predoctoral trainees for productive research careers in the field of signaling and cellular regulation. The training faculty mentors consist of an outstanding, internationally recognized group of researchers in the Department of Biochemistry and the Department of Molecular, Cellular and Developmental Biology, who, by using the highest standards of scientific rigor and reproducibility, have made major breakthroughs towards the discovery and characterization of new mechanisms for biological cell signaling and regulation. The program will mentor students to gain critical thinking skills and depth in understanding how to assimilate different scientific areas to solve problems in modern molecular biosciences, and teach them how to use apply these skills when they enter the biomedical research workforce. Program elements will include program-specific elective courses, an annual Symposium, Supergroup research conferences, seminars, and journal clubs, together with trainee monitoring through thesis committees and organizational meetings. These approaches will expose students to broad, interdisciplinary scientific areas through cross-disciplinary mentorship, collaboration, and team building; provide them with rigorous training in experimental design, classical and modern technologies, and data analysis, with high standards for reproducibility; and support students’ progress and ability to work in teams through all aspects of their training. Coursework on responsible conduct of research will instill students with an awareness of norms and expectations for conducting research with high ethical standards. Professional development and career training workshops will expose students to career trajectories and opportunities, with experiential coaching for planning and landing employment. By integrating SCR Program-specific coursework and activities with departmental graduate program requirements, and through mindful and responsive mentoring, we will create a thriving collaborative and interdisciplinary graduate training environment.

Public health relevance
NARRATIVE The goal of this training grant is to prepare the next generation of scientists who will conduct high quality research leading to new discoveries in biomedicine. The research focus of students who train in our program is to understand fundamental mechanisms in signaling and cellular regulation, an area which is key to the discovery of new therapeutic treatments for human diseases such as cancer, diabetes, inflammation, heart disease, immunological and neurological disorders, and birth defects, and forms the foundation for modern research in biology and medicine.